Mechanism by which SGLT2 inhibitor treatment regulates skeletal muscle fuel metabolism

Sodium-glucose cotransporter-2 inhibitors (SGLT2i) are type-2 diabetes (T2D) medications designed to
promote urinary glucose excretion that are increasingly associated with unanticipated health benefits. Growing
evidence indicates SGLT2i have off-target effects that improve insulin action, including studies in humans and
mouse models of obesity. The effect has been attributed to enhanced skeletal muscle insulin action, yet
remains untested. The mechanistic explanation as to how SGLT2i may enhance skeletal muscle insulin action
also remains unknown. These gaps in knowledge indicate unrealized therapeutic potential of SGLT2i. Taken
together, there is a critical need to determine the impact and underlying mechanisms of SGLT2i treatment on
regulation of skeletal muscle metabolism. Our long-term goal is to identify strategies to improve skeletal
muscle metabolic health and lower disease risk. Our objective in this application is to determine mechanisms
by which SGLT2i modulate skeletal muscle metabolism as part of an expanded model of SGLT2i treatment.
Our overall hypothesis is that SGLT2i have direct actions on skeletal muscle to increase glucose uptake as a
function of inhibiting mitochondrial complex I and activation of AMP-activated protein kinase (AMPK). The
hypothesis is supported by strong preliminary data. We provide new evidence that SGLT2i treatment improves
glucose uptake in skeletal muscle as a function of enhanced insulin signaling. We demonstrate these effects
are likely attributable to direct actions on skeletal muscle, whereby all 4 FDA-approved SGLT2i cause dose-
dependent inhibition of mitochondrial complex I and activation of AMPK. Importantly, our new findings of off-
target mechanisms of action of SGLT2i on muscle identify clinical relevance to determine overlap with
metformin (a common T2D co-therapy) on complex I metabolism. The following aims test specific hypotheses
of our overall model. Aim 1: Determine the role of complex I inhibition for SGLT2i regulation of skeletal muscle
metabolism. We will determine the effects of SGLT2i treatments on skeletal muscle mitochondrial
bioenergetics and insulin action in western diet fed mice using both acute and chronic treatment strategies.
Aim 2: Identify the requirement of AMPK for SGLT2i regulation of skeletal muscle metabolism. We will use an
inducible, skeletal muscle-specific AMPK knockout model then determine glucose uptake in isolated tissues
and mitochondrial bioenergetics. Aim 3: Identify combination of canagliflozin and metformin treatment on
complex I metabolism. We will treat mice with metformin then determine combination with either canagliflozin
or empagliflozin on complex I respiratory function in skeletal muscle and liver. The proposed studies can be
expected to provide new information regarding how SGLT2i regulate skeletal muscle metabolism and
contribute to improved metabolic health. The work will establish a new proposed mechanism of action for a
widely used class of medications, new mechanistic understanding of interaction during combined SGLT2i and
metformin treatment, and evidence to support new applications for use of SGLT2i.

Public health relevance
Excessive weight increases risk for development of prediabetes and type-2 diabetes, due in part to impairments in skeletal muscle metabolism. This project will provide new understanding of the mechanisms and therapeutic potential of using sodium-glucose cotransporter-2 (SGLT2) inhibition as a treatment for impairments to skeletal muscle metabolism associated with weight gain and obesity.